Dissecting the Mechanisms of Regulation and Quality Control in Ribosome Assembly and the Consequences of their Failure

ABSTRACT
Ribosomes carry out protein synthesis in all cells, interpreting the information contained in the mRNA to produce
the proper amount of the correct protein. In addition, ribosomes also mediate mRNA quality control. Thus,
misassembled, or damaged ribosomes as well as insufficient ribosome numbers can affect the sequence and
abundance of proteins and mRNAs, thereby disrupting protein homeostasis. This can lead to a number of
diseases, demonstrating the importance of ensuring ribosomes are accurately assembled, and produced in the
correct numbers.
Using a combination of biochemical, genetic, genomic, and structural tools, we will (i) investigate mechanisms
that enable ribosome production by avoiding RNA folding traps and dead-end intermediates, (ii) dissect quality
control pathways to identify misassembled intermediates, (iii) study how defective ribosomes are identified for
repair or degradation, and (iv) explore how ribosomes are remodeled to alter translation.
In the first part, we will build on work in the current funding period to study the role of ordered helix formation and
snoRNA binding for rRNA folding. This work has implications for the larger field of RNA folding, and RNP
assembly, as well as the ribosome heterogeneity community, which is focused on snoRNA-mediated
modifications. Our work indicates that snoRNA deletions affect ribosome assembly, which must be broadly
considered in the study of ribosome heterogeneity.
In the second component, we will extend our work on quality control to investigate a possible proofreading
mechanism that quality checks the formation of the key functional feature of the small ribosomal subunit, the
decoding site.
In the third area, we will study the mechanisms of ribosome repair and degradation to decipher how cells make
decisions about different outcomes from one complex, collided disomes.
In the last section, we will study how the ubiquitin proteasome system is linked to ribosome remodeling via
degradation of released RPs, and then dissect additional biological roles for these remodeled ribosomes.
Together, the proposed work will provide a comprehensive picture of ribosome homeostasis, which underpins
protein homeostasis and is thus critically important to prevent human diseases including cancer and
neurodegeneration.

Public health relevance
PROJECT NARRATIVE The long-term goal of the proposed research is to understand the mechanisms of ribosome homeostasis: How cells ensure that enough ribosomes are produced and that these have the correct structure and composition, and how they identify and then degrade or repair damaged or defective ribosomes. These questions will be addressed in a combination of biochemical, genetics, genomics and structural tools, largely using yeast as a model organism.